ON and OFF visual signaling in the retinal interneurons

Abstract
Retinal neurons utilize multiple antagonistic mechanisms to shape visual signal processing, such as ON and
OFF signaling, antagonistic center-surround, rod- and cone-signaling, and transient and sustained signaling.
Among those signaling mechanisms, ON vs. OFF signaling is coded to morphologically distinct groups of
retinal neurons, bipolar, amacrine, and ganglion cells. Retinal neurons that ramify in the inner region of the
inner plexiform layer (IPL) respond to the onset of a light stimulus, called ON cells. In contrast, OFF cells
ramify in the outer region of the IPL and respond to the offset of a light stimulus. Since being discovered
several decades ago, there appeared to be no exceptions to this morpho-physiological rule for ON and OFF
signaling. However, recently, some exceptions have been revealed. We found that ON and OFF signaling
switches in starburst amacrine cells and bipolar cells. We also found that light adaptation plays a crucial role in
the ON and OFF sign switch. In the mesopic light condition, both rods and cones are active, generating a
complicated interaction. However, light-evoked responses in retinal interneurons, including bipolar and
amacrine cells, have not been systematically investigated over a wide range of ambient light levels. In our
proposed studies, we will test the hypothesis that the rod-cone interaction in the mesopic condition converts
the ON and OFF signs of light responses in retinal bipolar cells and amacrine cells. The long-term goal of the
proposed study is to examine how the ON and OFF sign switch occurs in the interneuron and how this plays a
role in shaping spikes in ganglion cells. We will use wholemount retinal preparations to conduct a patch clamp
study of bipolar and amacrine cells to determine the visual signal signs in response to various light stimuli.
Especially, we will assess the light-evoked excitatory postsynaptic potentials (L-EPSPs) over a wide range of
background light conditions. We will also examine the L-EPSPs at the mesopic condition after the tissue is
adapted to scotopic or photopic conditions (Aim 1). Also, we will determine how retinal antagonistic signaling
systems shape the ON and OFF signs. We will test potential underlying mechanisms, including the rod-cone
signaling interaction, the dopaminergic system, the antagonistic surround by inhibitory amacrine cells, and the
ON-OFF signaling pathway interaction (Aim 2). Then, we will examine the outcome of the switch by conducting
the Calcium imaging from the starburst amacrine cells (Aim 3). Understanding the mesopic vision is essential
because both rod and cone dysfunction cause reduced vision in the mesopic vision.

Public health relevance
Narrative Retinal neurons exhibit either excitation or inhibition to light inputs. In the dim light ambient conditions, two kinds of photoreceptors may interrupt each other, inducing mixed excitatory and inhibitory responses in the downstream neurons. We will investigate the cellular light responses and the mechanisms because both rod and cone dysfunction cause reduced vision in the mesopic vision.